Pathology Core

PROJECT SUMMARY/ABSTRACT
The Pathology Core will be co-led by Dr. Marisa Nucci, a pathologist with expertise in gynecologic neoplasia,
and by Dr. Geoffrey Shapiro, who brings experience with biomarker development for DNA repair inhibitor-based
preclinical and clinical work. The core will provide support for all of the projects, focused on targeting replication
stress and DNA damage response in women with advanced endometrial cancer, including (1) WEE1 inhibition
in uterine serous or TP53-mutant uterine cancers; (2) combined ATR/PI3K inhibition in uterine cancers; and (3)
induction of replication stress to activate the cGAS/STING pathway to generate anti-tumor immunity in uterine
cancers. The Core will ensure quality control of data generated from human and mouse tissues in each of the
projects and carry out unbiased analyses of results utilizing proper controls. The goal of Aim 1 is to provide
histologic assessment and confirmation of experimental models via the application of standard criteria for
endometrial cancer diagnosis, along with immunohistochemical analyses to confirm Mullerian origin and
histologic subtype in both parental tumors and in organoid or patient-derived xenograft models generated from
those tumors. Models will be assessed serially to ensure that they retain fidelity to the primary tumors from
which they were derived. The primary objective of Aim 2 is to analyze immunohistochemical biomarkers of DNA
damage (g-H2AX, pKAP1), replication stress (pRPA, pKAP1), ATM deficiency, oncogene activation (cyclin E,
MYC) and homologous recombination repair proficiency (RAD51 foci). The characterization of models and
tumors pre- and on-treatment with the WEE1 inhibitors adavosertib and ZN-c3 or with a combination of the PI3K
inhibitor copanlisib and the ATR inhibitor elimusertib will determine if these biomarkers are predictive of response
and will confirm target engagement by these agents. In Aim 3, models and primary tumors subjected to WEE1
and ATR inhibitor-based treatments will be interrogated for changes in the immune microenvironment using a
validated multiple immunofluorescence platform that will quantify T-cell infiltrates and subtypes along with
immune checkpoint protein expression. Changes in the immune microenvironment will be correlated with DNA
damage and replication stress biomarkers, activation of the cGAS/STING pathway and with clinical outcomes.

Public health relevance
PROJECT NARRATIVE Endometrial cancers carry genomic features of replication stress and endogenous DNA damage that may make them susceptible to treatments that induce further replication stress above a lethal threshold. Projects in this proposal will study WEE1 and ATR inhibitor-based treatments in organoid and mouse models, and in clinical trials. The Pathology Core will offer histologic quality control for model development, conduct immunohistochemistry for predictive and pharmacodynamic markers related to DNA damage, replication stress and DNA repair, and oversee multiplex immunofluorescence for interrogation of the immune microenvironment, in order to identify subsets of patients likely to benefit from these treatments and to determine if response is related to the activation of innate immunity. The Core will bring expertise in Gynecologic Pathology and DNA Repair to the entire endeavor of studying replication stress in endometrial cancers to reduce the burden of this disease and to improve patient outcomes.